Research Core

The BBC will be designed with four major pillars in mind to assist the RPLs in their proposed studies and develop an infrastructure in bioinformatics and biostatistics for the support and capacity of the pipeline investigators and UPR researchers in the future. The goal of the BBC is to serve as an expert hub to address bioinformatics and biostatistics necessities, initially for the RPLs, but also it will serve as a training pipeline for early-stage investigators invested in cancer research. The BBC will provide infrastructure and resources to enhance the ability of investigators to develop competitive research proposals with robust research design methods, as well as high-quality scientific publications.